Research Training/Education Core

The Research Training/Education Core will establish a comprehensive set of training and mentoring activities intimately linked to our overall multilevel conceptual model, and integrated with the Research Projects. We will build on, extend, and formalize the set of training and mentoring activities successfully implemented during the prior funding period. The Core will coordinate the educational activities intimately linked to two major CIAHD goals: (1) enhancing training necessary to develop an understanding of multilevel determinants of minority health and health disparities with a special focus on integrating social and biological factors; and (2) building on our collaborative partnership with the Jackson Heart Study (JHS) and on the network of junior investigators linked to CIAHD through our annual symposium for young scholars. The Specific Aims of the Training/Education Core are: (1) To enhance training in integrative, multilevel approaches to minority health and health disparities research for graduate students at the University of Michigan (Michigan), Jackson State University (JSU), and the University of Mississippi Medical Center (UMMC) through participation in short courses, workshops, and research seminars offered at Michigan and active engagement in on-going research activities. (2) To expand training, education, and mentoring activities for postdoctoral fellows and junior faculty in integrative, multilevel approaches to minority health and health disparities research at Michigan, JSU, and UMMC. (3) To create broad-based forum for periodic training, education, career mentoring and general interactions for junior investigators in the integration of social and biological determinants of minority health and health disparities across multiple levels by sponsoring an annual scientific symposium in Jackson for young minority investigators for the purposes of research dissemination, skill-building, professional development, and networking. Training and mentoring activities will be closely linked to our integrated conceptual model, integrated within the research projects, and will expand on and formalize the very successful training and education partnership established with the Jackson Heart Study as part of the prior funding period.

Public health relevance
Research education and training in our multilevel integrated approach is fundamental to conducting research that provides new insights into the determinants of health disparities and the most interventions/policies likely to be most effective in eliminating disparities.